Continuation of the Chronic Renal Insufficiency Cohort Clinical Centers (CRIC)

Program Director/Principal Investigator (Last, First, Middle): Rahman, Mahboob
Abstract
The Chronic Renal Insufficiency Cohort (CRIC) Study enrolled adults with chronic kidney
disease to address overarching goals of identifying predictors of progression of kidney disease
and clarifying the relationship between kidney dysfunction and cardiovascular disease. The next
phase of CRIC extends follow-up through 2023, and adds novel measures that challenge
current paradigms of measurement of kidney function and cardiovascular disease. The Case
Western Reserve University Clinical Center has the following specific aims: 1) To re-enroll a
high percentage of existing participants and obtain center-based assessments 2) maintain high
levels of participant retention 3) To identify novel cardiovascular phenotypes using remotely
collected data and determine their relationship to clinical outcomes 4) to examine sub-clinical
acute declines in kidney function using remotely, collected data and determine their relationship
to clinical outcomes 5) to investigate self-reported cardiovascular and renal events and obtain
supporting medical records and documentation, 7) To implement effective quality assurance
procedures to ensure high-quality measurements, 8) To participate in governance of CRIC 9) To
publish findings from CRIC, 10) to conduct approved CRIC ancillary studies, 11) To facilitate
novel methods in biostatistics and bioinformatics to analyze complex datasets incorporating a
multitude of exposure and outcome variables, 12) To engage investigators at the Case Western
Reserve University to assist in local analysis of CRIC data, to conduct ancillary studies, 13) To
engage investigators in the broader scientific community to participate in CRIC. We will focus on
non-linear trajectories of kidney function, and identify novel cardiovascular phenotypes by
integrating physiological parameters and continuous measures of physical activity, and
determine their relationship to clinical outcomes. These efforts will allow us to understand the
physiology and progression of kidney disease better by incorporating measures taken at home
in the patient's usual setting, and may result in novel therapeutic targets for chronic kidney
disease.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Rahman, Mahboob Project Narrative The CRIC study is designed to study the reasons why kidney disease progresses over time, and to identify factors that contribute to development of heart disease. Over the last 15 years, this study has established an impressive infrastructure; we now propose to extend this study for another 5 year period and also obtain measurements of kidney and heart function as patients go about their usual daily activities. This will help advance our understanding of kidney disease, and how it influences heart disease.